Sleep Interventions and Neurocognitive Outcomes in Amnestic Mild Cognitive Impairment

Project Summary / Abstract
This proposed Mentored Patient-Oriented Research Career Development Award (K23) will provide Hyun Kim,
PhD, a post-doctoral fellow at Columbia University, with research training and career development that will
help her become an independent and expert sleep scientist in Alzheimer's disease and related dementias
(ADRD) research. Poor or fragmented sleep increases the risk of cognitive impairment and Alzheimer's
disease (AD) through accumulation of amyloid-β, spread of tau, and accelerated microglial activation. While
sleep's connection to brain and cognitive function is widely established, it is unclear whether modifying sleep in
older adults could delay cognitive decline and slow the development of AD. Understanding the impact of sleep
treatments on cognitive changes could enhance the current understanding of sleep disturbance as a modifiable
risk factor and establish sleep interventions as a potential tool to reduce AD risks. The primary aim of the
proposed research project is to examine neurocognitive performance outcomes of cognitive behavioral therapy
for insomnia (CBTI) and acoustic slow wave activity enhancement (SWAE). The mechanism of treatment-related
neurocognitive changes will be investigated using the changes in objective and subjective sleep
parameters. The secondary aim is to examine the impact of sleep treatments on cognitively-mediated everyday
functioning. The exploratory aim is to assess whether CBTI and/or SWAE are associated with plasma AD
biomarker, namely phosphorylated tau. These research aims will be complemented by career development
plans involving (1) enhancing scientific knowledge in sleep and AD neurobiology; (2) developing skills in
clinical trial methodology and relevant analytic skills; (3) fostering professional development and networking in
sleep and AD scientific community. Collectively, the proposed study, in its research question, scope, and
structure, is designed to serve as a road map for future R01 studies that investigate the intricate relationship
between sleep and ADRD.

Public health relevance
PROJECT NARRATIVE There is accumulating evidence indicating that sleep disturbance could lead to Alzheimer's disease (AD) pathology and related cognitive decline; therefore, understanding the effects of sleep interventions on cognition could enhance our understanding of sleep disturbance as a modifiable risk factor for AD. The current K23 proposal aims to examine this important research question by investigating neurocognitive effects of two sleep interventions (cognitive-behavioral therapy for insomnia [CBTI] and acoustic slow-wave activity enhancement [SWAE]) and their underlying mechanisms in individuals with amnestic mild cognitive impairment (aMCI). The overarching goal of this project is to support a research career to study sleep interventions as novel therapeutic approaches to prevent or delay AD progression.